Research Project 1

Cervical cancer is the leading cause of cancer-related deaths in South Africa where incidence and mortality rates
are expected to rise, in part due to the largest global burden of HIV epidemic in women. Based on strong empirical
evidence, WHO recommends Human Papillomavirus (HPV)-based testing followed by immediate treatment, an
approach called screen-and-treat, as the optimal way to screen for cervical cancer in low- and middle-income
countries (LMCIs) where fragmented care and inadequate infrastructure introduce delays in conventional multi-
step screening process of referral, histological confirmation, and treatment (e.g., cytology-based screening). Our
team’s decades-long international collaborative research has developed the evidence base and the capacity for
implementing HPV-based screening in primary care and generated preliminary implementation data for a Point-
of-Care HPV-based Screen-and-Treat (POC-SAT) approach that enables women to undergo, in a single visit,
HPV testing, evaluation for, and, if indicated, treatment. To promote successful and equitable implementation of
this evidence-based intervention, we propose to develop and assess contextually-informed and scalable
strategies for integrating POC-SAT into public health primary care setting in Khayelitsha, an impoverished
geographic area of predominantly Black residents in the Cape Town metropolitan area. Using stakeholder
participatory processes and drawing on newly revised and LMIC-focused versions of Consolidated Framework
for Implementation Research (CFIR) framework, we will undertake a systematic assessment of multilevel
determinants of POC-SAT implementation within the local primary care context through a) key informant
interviews and b) facility mapping (Aim 1). We will use this assessment to identify, prioritize and refine a package
of tailored strategies for POC-SAT implementation through a) matching stakeholder and facility-level barriers to
a range of implementation strategies listed in the Expert Recommendations for Implementing Change
compilation, and b) seeking stakeholder and expert feedback and endorsement for prioritizing and packaging a
set of implementation strategies using a modified Delphi process (Aim 2). Finally, we will conduct a mixed-
methods evaluation of the POC-SAT implementation to assess the outcomes of a) adoption and reach of POC-
SAT and tailored strategies, and impact on treatment completion (primary outcomes), and b) feasibility,
acceptability and appropriateness among multiple stakeholder groups (secondary outcomes) (Aim 3). The
Project activities synergize closely with the objectives of the Empilisweni Center Cores and Project 2, as well as
with provincial Department of Health efforts to accelerate the integration, implementation and scale-up of
equitable cervical cancer control among women in South Africa. Findings from this project will advance the
current knowledge of optimal processes for the development and refinement of implementation strategies in
LMICs, laying the groundwork to understand and tackle implementation challenges for achieving equitable global
cervical cancer control.